Core B - Pathology and Biospecimen Core

Project Summary
The acquisition, pathologic analysis and molecular characterization of human and mouse model
gastrointestinal (GI) samples is an integral requirement for all portions of this SPORE. This
Core will continue to provide SPORE investigators multiple pathology services to support
Research Projects and future Career Enhancement Program (CEP) and Developmental
Projects (DP) awardees. We will work in close collaboration with investigators to achieve three
crucial purposes: i) to provide tissue specimens and pathology expertise to evaluate human and
mouse models of GI neoplasms; ii) to provide molecular pathologic expertise in state-of-the-art
molecular evaluation of tissue specimens; and iii) to evaluate and implement new tissue and
cellular imaging and analysis technologies that will benefit these research goals in the future.
Centralization of Core activities builds upon established infrastructure and expertise of these
investigators, and complements but does not replicate existing infrastructure in our Cancer
Center and provides a valuable component to the analysis of biological resources developed
and utilized by SPORE investigators. To bring pathology based scientific support to all SPORE
projects, this Core proposes the following specific aims:
Specific Aim 1: To provide human biospecimen procurement and distribution.
Specific Aim 2: Generation of models for pre-clinical trials
Specific Aim 3: Pathologic characterization of human and mouse GI tumors using molecular
pathology tools and emerging new technologies

Public health relevance
Project Narrative The Biospecimen and Pathology Core will work in close collaboration with investigators to achieve three crucial purposes: i) to provide tissue specimens and pathology expertise to evaluate human and mouse models of GI neoplasms; ii) to provide molecular pathologic expertise in state-of-the-art molecular evaluation of tissue specimens; and iii) to evaluate and implement new tissue and cellular imaging and analysis technologies that will benefit these research goals in the future.